PROVIDE SERVICES AND DELIVERABLES THROUGH PERFORMANCE OF TECHNICAL SERVICES SPECIFICALLY FOCUSED ON WEBSITE DEVELOPMENT, DATA/DATABASE MANAGEMENT, AND SYSTEM INTEGRATION AND MAINTENANCE

Alzheimer's disease